EFFECTS OF TROGLITAZONE AND METFORMIN ON GLUCOSE METABOLISM

Protocol has been completed. This study showed that the effects of Troglitazone and Metformin are distinct, equal and additive and that their combined use is safe.